Tuning KITv CAR T cells for the solid tumor environment

PROJECT ABSTRACT
We developed and translated CD28 costimulated chimeric antigen receptor (M28z CARs) T cells that target mesothelin
(MSLN), a cancer-associated antigen that is overexpressed in a majority of solid tumors; 65 patients have been treated in
phase I/II trials, with no on-target, off-tumor toxicity. Having demonstrated that regionally administered CAR T cells avoid
pulmonary sequestration and are enhanced by early antigen-activated CD4 CAR T-cell helper function, we delivered M28z
CAR T cells intrapleurally in patients with malignant pleural mesothelioma (MPM), promoting tumor infiltration. To
overcome antigen stress–induced T-cell exhaustion, we treated 27 patients with MPM with an anti-PD1 agent after a single
dose of intrapleural M28zCAR T cells (median survival 18 months vs. 10 months following second line pembrolizumab).
To facilitate tumor-specific checkpoint blockade and to achieve functional persistence without repeated administration of
anti-PD1 agent, we translated a CAR T-cell–intrinsic PD1 dominant negative receptor (PD1DNR); 8 patients have been
treated, with no CAR- or PD1DNR-related toxicities. Recognizing the necessity of the IFNγ pathway for solid tumor killing
by CAR T cells, we exploited a c-KIT mutation, D816V (KITv), as a costimulatory domain (Nat Cancer 2023). A single
infusion of M28zKITv CAR T cells was safe, resisted TGFβ-mediated suppression, prolonged survival, and demonstrated
functional persistence in multiple solid tumor models including in low-antigen expressing tumors; clinically available kinase
inhibitors are effective as on/off, tunable safety switch. Herein, we hypothesize that, whereas IFNγ-mediated cytotoxicity is
the predominant mechanism of KITv CAR T cells against high-antigen-expressing targets, for low- or non-antigen-
expressing targets, IFNγ-mediated upregulation of ICAM1 on tumor cells facilitating LFA1(CAR T-cell)-ICAM1 synapse
(increased avidity) and apoptosis of IFNγ receptor–expressing target cells are the respective biologic mechanisms (Aim 1),
KITv-induced IFNγ potentiates the cytotoxicity of CD4 41BBz KITv CAR T cells against low-antigen-expressing targets
and that CD28 costimulation promotes the helper function of CD4 28zKITv CAR T cells; however, PD1DNR is essential
for functional persistence (Aim 2), and that PD1DNR-mediated checkpoint blockade extends beyond PDL1-expressing
tumor cells and counteracts PDL1-overexpressing M2 macrophages (Aim 3). The significance of our approach lies in its
effective combination of a solid tumor–specific scFv that is on target and safe (MSLN), costimulatory domains (KITv,
CD28), checkpoint blockade (PD1DNR), and tumor infiltration (regional delivery). The impact of our proposal extends
beyond pleural cancers; the majority of aggressive solid tumors express MSLN. The proposal’s innovations include—
exploiting IFNγ-mediated cytotoxic mechanisms in a heterogenous antigen-expressing solid tumor, increased CAR T-cell
avidity through a second synapse, potentiating CD4 CAR T-cell helper function to augment CD8 CAR T cells and
counteracting PDL1-expressing M2 macrophages by the CAR T-cell intrinsic PD1DNR.

Public health relevance
PROJECT NARRATIVE The success of chimeric antigen receptor (CAR) T-cell immunotherapy in patients with heterogenous antigen- expressing solid tumors requires effective cytotoxicity and functional persistence of infiltrating CAR T cells in an immunosuppressive environment. Herein, we propose to translate KITv CAR T cells by exploiting multiple IFNγ-mediated cytotoxic mechanisms and adding a PD1 dominant negative receptor to counteract tumor and macrophage mediated immunosuppression.